BIOANALYTICAL ANALYSIS FOR PHARMACOKINETICS OF UNDERSTUDIED DRUGS ADMINISTERED TO CHILDREN PER STANDARD OF CARE (POPS) IV and V

The Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD), under the authority of The Best Pharmaceuticals for Children Act (BPCA), requires study of Pharmacokinetics of Understudied Drugs Administered to Children per Standard of Care.